Research Training in Allergy and Clinical Immunology

Abstract
The goal of this project is to develop innovative physicians and PhD scientists trained in the latest methods of
laboratory, translational and clinical research and fully prepared to pursue independent research careers
investigating critical issues in Allergy and Immunology (A/I). For over 40 years this program has produced leaders
in the field of A/I. This application maintains the training collaboration established between the complementary
A/I training programs at Duke University and The University of North Carolina Chapel Hill (UNC). The
combined strength of their A/I programs and their respective Universities create an ideal venue for training
the next generation of A/I investigators. This proposal continues a highly innovative program for both
physicians and PhD trained scientists in translational research in immune- based diseases. These goals
will be accomplished through 1) formal courses in clinical research design, 2) rigorous training in basic
immunology and 3) a structured mentorship program. Our research emphasis areas are designed to
address these future needs in the field: 1) Human Immune Response to Pathogens, 2) Immunobiology
of Food Allergy and 3) Pathobiology of Asthma, Respiratory and Allergic Disease. Mentors were selected from
highly integrated and focused programs currently in place at Duke and UNC who demonstrated research
productivity. Additionally, in this cycle we will bring an increased focus to Diversity, Equity and Inclusion as well
as the mentor development of junior faculty who will become future established mentors. This application
requests support for five trainees each year. Fulfillment of the program's objective would directly or indirectly
serve to meet two urgent medical needs: 1) the need for more full-time researchers and teachers of allergy and
clinical immunology in medical schools throughout the country and 2) the need for more physicians trained
in the specific care of patients with allergic and immunologic disorders.

Public health relevance
Project Narrative To develop Allergists and Immunologists and PhD scientists optimally trained in translational research and fully prepared to pursue independent academic careers by capitalizing on the training infrastructure of two leading Universities: The University of North Carolina and Duke.